Integrated analysis of cancer risk and mortality in WTC survivors

Project Summary
The destruction of the World Trade Center (WTC) towers on September 11, 2001 resulted in the massive release
of dust and fumes with exposure of local community members (“survivors”) to carcinogenic compounds
(asbestos, metals, and dioxins). It is well known that environmental exposures can cause somatic mutations and
aberrant DNA methylation which, in turn, are known to be associated with cancer initiation and progression.
There have been a rapid increased of the number of cancers among community members affected by the terrorist
attack on the WTC towers on September 11, 2001. Studies of cancers from the FDNY and General Responders’
group report elevated cancer incidence in prostate cancers and other solid tumors among men. Importantly,
there are also several studies of WTC Responders enrolled in WTCHP medical monitoring and treatment
programs (MMTP) that find significantly lower mortality rates compared to national peer groups mortality rate.
These are important findings, however, the members of the FDNY and general responders are predominately
limited to white males thus lack the necessary diversity in gender, socioeconomic and race/ethnicity to fully
understand breast cancers and other leading cancers in the affected urban community. Studies performed by
the NYCDOH WTC Health Registry report increased cancer incidence rate in women’s breast cancers among
community members, but are based on epidemiological data from survey questionnaires thus lack of individual
level clinical information. Moreover, there has been no investigation on the link between the complex WTC
exposures and the phenotypes and mortality of cancers in WTC Survivors enrolled in the WTC Environmental
Health Center (EHC), Williams Street Clinic (WSC) and National Provider Network (NPN), the CDC/NIOSH
designated treatment and monitoring program for affected community members (i.e. survivors). In particular, the
enrollees of WTC EHC include about 50% women and have diverse social-economic status and racial/ethnic
background. To fill the important knowledge gaps and to improve disease surveillance, diagnosis and treatment
activities for cancer among affected community, we propose to conduct integrated analyses of individual-level
patient data to investigate the link between WTC exposures and certified WTC cancers at the WTC EHC and to
measure cancer mortality in survivors. We will systematically examine WTC exposures and other risk factors
and associations with breast cancer characteristics and cancer survival outcomes. Successful completion of this
project will establish the link between elevated WTC exposures with combination of other risk factors and
characteristics of breast cancers, and characterize effects of risk factors associated with breast cancer stage,
subtypes, and overall survival among community members affected by the WTC terrorist attack, which can inform
subsequent studies and improve surveillance and treatment of the WTC-exposed population.

Public health relevance
Project Narrative Twenty years after the World Trade Center (WTC) terrorist attack on September 11, 2001, there is a rapid increase in the number of diagnoses and mortality of women’s breast cancer and other cancers. To improve cancer surveillance and treatment for WTC cancers, we propose to conduct integrated analyses of cancer risk and mortality and associated risk factors in WTC survivors enrolled at the New York City Health and Hospitals WTC Environmental Health Center (NYC H+H WTC EHC), Williams Street Clinic and National Provider Network, three CDC/NIOSH-designated treatment and surveillance programs for exposed community members (i.e. survivors). We propose to integrate data on WTC exposures and other risk factors and test their associations with the breast cancer characteristics, and survival using individual-level patient exposure, clinical, outcome data available at the Survivor Data Center (SDC) which hosts the pan-cancer database.